Metabolic control of normal and malignant hematopoiesis

PROJECT SUMMARY/ABSTRACT
Somatic mutations in the isocitrate dehydrogenase (IDH) enzymes contribute to the pathogenesis of acute
myeloid leukemia (AML) and other malignancies via production of the ‘oncometabolite’ D-2-hydroxyglutarate
(D-2HG). D-2HG blocks differentiation of malignant cells by inhibiting alpha-ketoglutarate (KG)-dependent
enzymes that regulate chromatin structure and gene expression. Small molecule inhibitors of mutant IDH
enzymes are promising new therapies for AML, but their efficacy remains limited to the subset of patients with
IDH mutations. This raises the question as to whether analogous metabolic aberrations might contribute to
leukemogenesis in IDH-wildtype AML. Intriguingly, 2HG is a chiral molecule that can exist in either the D- or L-
enantiomer. Although cancer-associated IDH mutants exclusively produce D-2HG, biochemical studies
indicate that L-2HG can function as a ~10-fold more potent inhibitor of many KG-dependent enzymes,
including chromatin modifiers and regulators of hypoxia-inducible factor (HIF) stability. However, biological
sources and activities of L-2HG have been poorly understood. We identified a metabolic pathway wherein
normal and malignant cells without IDH mutations selectively produce L-2HG in response to oxygen limitation
(a.k.a. hypoxia) through an unusual reaction catalyzed by lactate dehydrogenase (LDHA). We show that
hypoxia-induced L-2HG enhances stability of HIF, increases repressive chromatin modifications, and blocks
differentiation of stem/progenitor cells. These findings suggest that L-2HG might account, at least in part, for
the importance of hypoxic niches, HIF, and LDHA in balancing self-renewal and differentiation of stem cell
populations, including hematopoietic stem/progenitor cells (HSPC) and leukemia stem cells. Thus, we
hypothesize that L-2HG functions as a metabolic signal that couples hypoxic niches to the
maintenance of normal blood stem cells and leukemia stem cells. This hypothesis will be rigorously
addressed in three Specific Aims. Aim 1 will define the molecular mechanisms by which L-2HG regulates
blood cell differentiation in vitro. In this Aim, we will define the effects of L-2HG on gene expression and
chromatin structure and determine how these inputs balance HSPC stemness and lineage differentiation. Aim
2 will determine how L-2HG functions to control normal and malignant hematopoiesis in vivo. This Aim will use
novel genetically engineered mouse models that allow for tissue-specific, inducible manipulation of L-2HG
levels in order to dissect the role of L-2HG in normal hematopoiesis and leukemia. Aim 3 will elucidate the
oncogenic mechanisms and therapeutic potential of L-2HG in human leukemia. In this Aim, we will use primary
AML biospecimens and patient-derived xenografts to determine the mechanisms that lead to deregulated L-
2HG in a subset of AML and assess whether depleting L-2HG offers a promising strategy to treat human AML.
The proposed studies will offer fundamental insights into the metabolic control of normal and malignant stem
cell biology and expand the applicability of metabolic targeted therapies for leukemia and other cancers.

Public health relevance
NARRATIVE New drugs that target metabolic pathways have shown promise for the treatment of cancer, but the benefits of these drugs have been restricted to rare patients whose cancers have mutations in metabolic enzymes. We have identified a metabolic pathway whereby normal stem cells and almost all cancer cells produce a metabolite called L-2-hydroxyglutarate (L-2HG) that regulates key aspects of cell identity and function. The proposed research will test the importance of L-2HG in normal blood stem cells and leukemia cells to determine how L-2HG affects cells and whether targeting the L-2HG pathway represents a useful and broadly applicable strategy for treating cancer.